Light, near work, and ocular remodeling and during emmetropization and myopia development in children

PROJECT SUMMARY/ABSTRACT
Myopia, or nearsightedness, is an epidemic, with up to 90% of the population in some urbanized countries
affected. Efforts have increased to understand the regulatory mechanisms underlying myopic eye growth due to
the potentially blinding complications and socioeconomic burden associated with myopia. The long term goal of
this work is to provide the scientific basis for effective environmental and behavioral treatment options to slow
myopia onset and progression in children and to better understand structural changes in the myopic eye that
render it more susceptible to ocular pathologies. Our central hypothesis is that reduced high intensity light
exposure and increased time engaged in near work contribute to myopia onset and progression. We also
hypothesize that the choroid, inner retinal vasculature, retinal morphology, and optic nerve head undergo
significant remodeling during myopia development, which contribute to associated pathologies later in life.
Refractive development is regulated by a complex interaction between genetic, environmental, and behavioral
factors. Evidence suggests that outdoor time is protective against myopia onset, with some studies also showing
that outdoor time decreases myopia progression. Numerous studies strongly support a role of near work in
myopia onset and progression. However, there are conflicting findings, with some studies reporting no
association. Inconsistent results are due to the variable and subjective nature by which light exposure and near
work have traditionally been assessed. Based on gaps in the existing literature and our preliminary work, we will
carry out the following studies to quantify the effects of environment and behavior on eye growth and the effects
of eye growth on ocular structure in children; each aim will follow children for a two-year period. 1) Longitudinal
objective and continuous measurement of personal light exposure over five one-week periods to determine its
influence on refraction and axial length change; 2) Longitudinal objective measurement of near work over five
one-week periods, paired with a visual activity questionnaire, to determine the influence of near viewing
behaviors and electronic device use on refraction and axial length change; 3) Optical coherence tomography
(OCT) imaging, OCT angiography (OCTA), and adaptive optics scanning laser ophthalmoscopy (AOSLO)
imaging at one year intervals to investigate changes in foveal cone photoreceptor density, foveal pit morphology,
foveal avascular zone characteristics, choroidal thickness, inner retinal vascular perfusion, and optic nerve head
parameters in association with refraction and axial length change. The proposed studies are intended to fill a
critical void in our understanding of the precise influence of environmental and behavioral factors on eye growth
and myopia and how the eye remodels in myopia. This work will contribute to the development of evidence-
based therapies, thereby reducing ocular complications and socioeconomic burden related to myopia.

Public health relevance
PROJECT NARRATIVE Myopia is an epidemic, with up to 90% of the population in select urbanized countries affected, bringing with it potentially blinding complications and a significant socio-economic burden. Our proposed studies aim to quantify the role of light exposure and near work on myopia and to determine how the myopic eye remodels. Findings will contribute to our understanding of the etiology of myopia, susceptibility of the myopic eye to pathology, and the development of targeted environmental and behavioral treatment options in children.